Community Cancer Control Outreach Core

COMMUNITY CANCER CONTROL OUTREACH CORE (CCCOC)
PROJECT SUMMARY/ABSTRACT
Despite lower overall cancer incidence and mortality among Hispanics compared with non-Hispanic whites,
rates of infection-related cancers are up to twice as high in Hispanics. For example, both Puerto Rico (PR) and
Texas (TX) Hispanics experience a substantial burden of hepatitis and human papillomavirus (HPV) -related
cancers. There is an urgent need to intervene to reduce these cancers in both settings. As part of the
UPR/MDACC Partnership for Excellence in Cancer Research, the Community Cancer Control Outreach Core
(CCCOC; Outreach Core) proposes an integrated community-based participatory approach to identify needs
and priorities and to develop multilevel outreach and educational interventions targeting cancers caused by
infectious agents. During the past decade, the CCCOC has made significant contributions to increasing cancer
control education, behaviors, and access to services to decrease cancer health disparities in Puerto Rico.
These efforts have identified and produced innovative outreach strategies and educational materials to reach
the most vulnerable and underserved populations on the island. This new funding period will represent
extension of our previous research and community work. The Outreach Core will build on previous
partnerships and networks, to improve community engagement and outreach to disseminate research findings
and interventions related to HPV vaccination and cervical cancer screening implemented in both PR and TX.
DATAOmics will provide data analysis support for the evaluation of the adaptation and implementation of these
interventions (Aim 1). The Outreach Core will also contribute to the Education Core mission and will build
capacity among IMPACT's scientists and students in areas such as community engagement across the
research translation continuum and implementation science (Aim 2). Doing so will ensure community
engagement across activities of the IMPACT program to inform research questions, interpretation of data and
future studies. These efforts will also serve to accelerate and improve the adoption and implementation of
research findings, guidelines, and interventions for cancer prevention and control in PR, TX and nationally
through our participation with the National Outreach Network (NON) (Aim 3). Following our initial focus on
HPV, we will expand our outreach and educational efforts to include a broader focus on infectious
malignancies of

Public health relevance
public health relevance in PR and TX. The Outreach Core will result in meaningful collaboration across a large network of partners in both PR and TX engaged in cancer control efforts. To ensure that activities and community impact are sustained beyond the funding period, we will develop the infrastructure, personnel and protocols for a permanent program of Cancer Control Outreach and Education integrated within the UPR Cancer Center.